Target Validation for I-BET151-Induced Differentiation in the African Trypanosome

PROJECT SUMMARY/ABSTRACT
African trypanosomes are protozoan parasites that cause severe and often fatal disease in a variety of mammals
in Sub-Saharan Africa, including humans (sleeping sickness). Like many other parasites, the African
trypanosome progresses through a series of distinct stages during its life cycle in its mammalian host and its
insect vector, the tse-tse fly, which dramatically differ in their metabolism, morphology, and virulence. There are
several critical gaps in our current knowledge of the molecular mechanisms that orchestrate the transitions
between these stages. Our long-term goal is to unravel the molecular basis of life-cycle stage regulation in the
African trypanosome and to harness this knowledge to manipulate the differentiation process for therapeutic
purposes. In recent experiments, we discovered that a small molecule called I-BET151, which was originally
designed as a human bromodomain inhibitor, has a profound effect on the long slender bloodstream form in the
mammal by transforming this virulent stage into the procyclic form, which is prevalent in the midgut of the tse-
tse fly vector. Importantly, this I-BET151-induced differentiation cripples the parasite’s defense mechanism such
as antigenic variation and, thus, renders it vulnerable by the host immune system, which can be exploited for
therapeutic purposes. Indeed, infection of mice with I-BET151-treated parasites resulted in an impressive
survival rate in comparison to mice infected with untreated trypanosomes. Before these proof-of-principle studies
can be translated into a new chemotherapy, we need to first understand and validate the mode of action of I-
BET151 in the African trypanosome, as the target(s) of I-BET151 that are responsible for the strong phenotype
in trypanosomes have not yet been identified. In this proposal, we seek to elucidate the target(s) of I-BET151 in
the African trypanosome using three complementary chemoproteomic strategies. In the first approach, we will
enrich I-BET151-interacting proteins by affinity capture on a bead matrix from trypanosome cell lysate, followed
by protein identification using mass spectrometry. To capture I-BET151 targets in a more physiologically relevant
condition, we will use in situ photo-crosslinking in trypanosome cells in the second approach and identify modified
proteins by mass spectrometry. In a third approach, ubiquitination and proteasomal degradation of I-BET151-
interacting proteins will be induced using bifunctional small molecules known as a PROteolysis TArgeting
Chimeras, or PROTACs, in which I-BET151 is conjugated to an E3 ubiquitin ligase-recruiting ligand. Collectively,
our proposed research will advance trypanosome biology by identifying proteins and complexes involved in
parasite differentiation. These studies will also stimulate research of life-cycle stage regulation in related
parasites that cause devastating mortality and morbidity worldwide. Finally, the proposed experiments will lay
the foundation for drug-induced differentiation therapy, which has the potential as a novel transformative strategy
to control and kill pathogenic parasites.

Public health relevance
PROJECT NARRATIVE African trypanosomes are protozoan parasites that cause fatal sleeping sickness. Our proposed studies aim to identify the targets of the small molecule I-BET151 that induces differentiation from the virulent bloodstream form to another, non-virulent life-cycle stage, which can be cleared by the mammalian host. This research will advance our mechanistic understanding of trypanosome life-cycle regulation and will lay the foundation for differentiation- induced therapy for sleeping sickness and potentially other parasitic diseases.